Clinical Pediatric Research Training for the Fetal-Neonatal Brain

SUMMARY/ABSTRACT
The rationale for this application is to fill the current void in clinical research training for the emerging discipline
of fetal-neonatal neurology. The rapid development of the fetal and newborn brain, and the unique genetic and
environmental factors that threaten such development, make the immature brain distinctly different from that of
even older infants. Yet, despite the growing recognition of the lifespan impact of events during this critical
period, clinical and research training in neurology of the fetus and newborn remains remarkably inadequate.
The objective of this program is to provide multidisciplinary training in clinical neuroscience research within the
context of the fetal/neonatal environment. Trainees will enter a two to three year program with an MD, DO,
PhD or MD/PhD. The primary site for the Clinical Research Training Program for the Fetal Neonatal Brain
is the Children’s National Health System (CNHS) in Washington, D.C. Training will be provided in the
responsible conduct of research, the acquisition of high-throughput ‘bedside’ clinical data in the NICU, and the
processing and analysis of data using sophisticated neurodiagnostic techniques. Two NIH-funded Principal
Investigators with complementary clinical and research expertise will be supported by neuroscience
preceptors (neurology, neuroradiology, neurogenetics), and mentors/subject matter experts from neonatal
intensive care, neonatal cardiac surgery, and clinical research methodology. The mentorship team is
assembled from Children’s National and the George Washington University (GWU). Children’s National is well
positioned to lead this program, based on (i) its strengths in translational and clinical research, and mentorship
in the central areas of inquiry; (ii) its formal funded research collaboration (CNICA Program) with Inova
Women’s and Children’s Hospitals, and (iii) the strength of its fetal and neonatal medicine programs. Each
trainee will develop special expertise in an advanced neurodiagnostic technique, complete a Master’s of
Science in Health Sciences Clinical (MSHS) at GWU or equivalent, and will design and implement a
research project overseen by her/his mentorship team. By graduation, the trainee will have presented his/her
data to at least one national research meeting, submitted one or more manuscripts to external peer-reviewed
journals, and have a well-formulated plan for a grant application. The program will prepare trainees with the
skills and expertise to develop into future leaders in the effort to reduce and prevent brain injury in the fetus
and newborn infant.

Public health relevance
PROJECT NARRATIVE The proposed T32 program for Clinical Research Training for the Fetal-Neonatal Brain will train the next generation of clinician-scientists in the research methodologies required to advance understanding of the developing human brain in vivo. The 2-3 year multidisciplinary research training program will focus on rigorous research methodology, advanced multimodal neurodiagnostic techniques for the fetus and newborn, and post- acquisition data processing, interpretation and analysis. The expertise developed will be critical for the formulation of future preventive neuroprotection strategies for the fetus and newborn.